COMPREHENSIVE SICKLE CELL CENTER

The purpose of this proposal is to describe activities of an ongoing Comprehensive Sickle Cell Center with specific programs in research, both basic and clinical, community education, education of medical and allied health professionals, genetic screening and counseling and in clinical care of patients with sickle cell disease. Programs are carried out for both adults and children. A total of 11 individual research projects are proposed. A unique feature of this proposal is the temporary amalgamation of two previously independent centers in order to provide a more coordinated effort. The amalgamation involves the combined efforts of the formerly independent King-Drew Center with those of the Center at the University of Southern California and the Los Angeles County--University of Southern California Medical Center.